Development Core

ABSTRACT – DEVELOPMENT CORE
The Development Core supports the CHIPTS mission by investing in emerging and diverse investigators who
seek to launch formative research activities to promote viral suppression for people with HIV and to reduce HIV
infections for at-risk communities. The work of the Development Core aligns with the CHIPTS theme of
addressing HIV-associated comorbidities, which include mental health and substance use disorders and
barriers in access to social and structural determinants of health. The Development Core proposes to leverage
traditional pilot and novel funding mechanisms aimed at supporting HIV prevention science among emerging
investigators with diverse backgrounds. Re-defined and reinvigorated mentorship and training activities link
senior faculty competent in mentoring scientists from racial/ethnic and sexual/gender minority backgrounds with
emerging investigators from these groups. Core services will catalyze the science of HIV prevention to address
the “whole person,” elevating resiliencies among those with HIV or at risk with comorbidities. The specific aims
are: (1) Science: To promote development of innovative, scalable, multidisciplinary research to address HIV
prevention and care for people with HIV or at risk with comorbidities. The core's mentored pilot grants, peer
review, and career and grant development activities nurture innovation, build leadership, and promote diversity
in HIV prevention, care, and implementation science research; (2) Networking: To establish new and nourish
existing relationships for CHIPTS investigators with providers, policy makers, and stakeholders to lead the next
generation of novel, multidisciplinary, high impact, HIV prevention science; (3) Capacity building: To promote
equity and diversity in mentoring and training of early-stage HIV prevention researchers; support trainees in
NIH-funded training programs; promote collaboration by co-sponsoring events that serve the needs and
interests of emerging and early-stage investigators and coordinate mentorship of emerging investigators with
diverse backgrounds to assure culturally competent mentor-mentee matching. The Development Core will
implement: (1) traditional pilot and new “kick start” seed grant programs; (2) a new “Bridge the Gap” fellowship
program; (3) new support for applications for NIH Diversity Supplements; (4) peer review and grant
development workshops; (5) conferences and other events to highlight research of new and emerging
investigators and to provide networking opportunities to foster new collaborative research targeting
comorbidities.